Imaging Core

IMAGING CORE: Project Summary
The onsite Imaging Core service module serves two critical functions to the research
productivity of the NEI Core Investigators and the surrounding research community. First the
Imaging Core designs, builds, and repairs advanced RF coils for MR imaging, which cannot be
obtained through commercial sources. Two examples of the importance of the coil lab in the
prior funding period are the special RF coils for human infants and marmoset monkeys.
Specialized coils for studying infant development, including the development of the visual
system are designed and built by the coil lab. These coils have given us unprecedented imaging
resolution and stability during infant development, which is one of our most challenging imaging
needs. Second, the Imaging Core provides consultation and workshops to faculty, students, and
postdocs on basic and advanced statistical analysis of functional MRI and
Magnetoencephalography (MEG) imaging data. Our experts in fMRI and MEG data analyses
have developed customized tools that are important to the work of our NEI Investigators, and are
also made available to all other researchers in our community.